EFIRM-Liquid Biopsy (eLB): Ultrasensitive ctDNA and miRNA Detection for Early Assessment of Lung Cancer

Project Summary/Abstract:
Computed tomography (CT) is currently the most sensitive test for detecting preclinical lung cancer, which
typically presents as an indeterminate pulmonary nodule (IPN). The success of CT for early detection was sealed
by the National Lung Screening Trial, in which lung cancer mortality was reduced by 20% relative to chest
radiography. However, in the NLST, the screen positivity rate was 24% and 96% of positive screens were false
positive. Although these percentages have been partially attenuated by new screening guidelines, it is axiomatic
that LDCT screening is highly sensitive for detecting lung cancer, but non-specific, and not without harms.
Furthermore, more individuals, both smokers and non-smokers, are diagnosed outside of screening based on
the finding of an indeterminate nodule. Methods are urgently needed to better differentiate between individuals
with benign disease and those should undergo invasive diagnostic testing. Liquid biopsy has found its way into
the cancer lexicon as a reference to tumor biomarkers within blood or other readily accessible biospecimens that
reflect the presence and biology of cancer. This precompetitive collaboration brings together academic and
industrial partners across the cancer spectrum to advance liquid biopsy technologies for early detection that are
viable as clinical tools. Our partnership interleaves the expertise of lung cancer biologists, clinicians, and
biostatisticians with industry engineers, converging on a novel liquid biopsy technology “EFIRM-Liquid biopsy
(eLB)” that has already shown high sensitivity detecting circulating DNA mutations in patients with EGFR-mutant
lung cancers. To address early lung cancer detection, our academic researchers will develop and validate
independent assays for 10 DNA mutations commonly observed in lung cancer as well as introduce a 6-biomarker
panel of miRNA to complement and strengthen the blood-based molecular signal of lung cancer. Our industry
partners will convert these individual assays to a single array while preserving high sensitivity and specificity.
With our clinician scientists, this integrated platform will be validated in patients with screen- or incidentally-
detected lung nodules in the size ranges that are most diagnostically challenging. Our overall research
proposition is that blood-based biomarkers using the eLB-Lung Cancer Detection Panel (eLB-LCDP) will inform
the accurate and robust classification of nodules as benign or malignant. Beyond contributing molecular and
technological expertise, standard operating procedures, and annotated clinical materials, we will compare eLB-
LCDP with other lung cancer-associated liquid biopsy platforms to be developed in this and related NCI consortia
to determine the highest performing biomarkers and platforms that should move to clinical translation, alone or
in combination with models that include clinical and imaging variables acquired as part of patient management.
Using this orthogonal, multiparametric interrogation approach, we hypothesize that the eLB-LCDP can achieve
a classification performance area under the receiver operating characteristic curve (AUC) > 0.85 in near real-
time clinical practice.

Public health relevance
Relevance to Public Health Statement This application proposes to apply a sensitive assay for blood-based lung cancer-associated molecular markers, EFIRM Liquid Biopsy (eLB), into the clinical management of patients with indeterminate lung nodules. Our platform will combine two distinct types of molecular biomarkers of lung cancer; when combined into a single assay, we anticipate that this technology will efficiently, accurately, and inexpensively distinguish between patients with benign or malignant nodules detected on computed tomography. Our goal is to advance this technology to clibical practice at the point of care.